Optimizing virtual hits of human CGAS inhibitors to treat neurodegeneration

Abstract
Aeton Therapeutics is developing inhibitors of cGAS (cyclic GMP-AMP synthase)—a pattern recognition receptor
that activates STING and results in the production of interferon (IFN)-β—as novel therapies for the treatment of
Alzheimer’s disease (AD). AD is the most common form of late-onset dementia and affects nearly 50 million
people worldwide and an estimated 5.7 million Americans. In 2020, total payments for healthcare, long‐term
care, and hospice services for people aged 65 and older with dementia were estimated to be $305 billion. The
cognitive decline associated with AD correlates with the formation of amyloid β (Aβ) plaques and neurofibrillary
tangles composed of hyperphosphorylated tau in the brain. Aeton Therapeutics seeks to produce a novel
therapeutic for AD by developing cGAS inhibitors (cGASi’s). cGAS is a cytosolic DNA sensing protein that has
been linked to a number of neurodegenerative and inflammatory diseases. Upon sensing DNA in the cytosol
(due to the presence of pathogens, genomic/mitochondrial damage, or other pathological mechanisms), cGAS
catalyzes ATP/GTP coupling to produce 2’3’-cGAMP, a potent ligand of STING, resulting in the production of
IFN-β. Previous studies suggest that cGAS is aberrantly activated in a tauopathy mouse model, resulting in an
IFN response and neurotoxic chronic neuroinflammation. In contrast, genetic ablation of cGAS in PS19 mice,
which overexpress P301S mutant tau and develop tau pathology and cognitive deficits, protects against those
cognitive deficits and the loss of hippocampal synapses. These findings strongly support the development of
cGASi’s to protect against the negative effects of cGAS-STING hyperactivation, but existing compounds exhibit
only modest potency in inhibiting the cGAS-STING pathway in human THP1 myeloid cells. To develop novel
cGASi’s to treat tau-mediated neurodegeneration in AD, in this Phase I project, Aeton Therapeutics proposes
the following aims: Aim 1. Develop potent h-cGASi’s via medicinal chemistry of virtual hits 1 and 2. We
have identified promising hits via a virtual screen. We will perform optimization and in vitro assessment of h-
analogs to identify lead candidates. Aim 2. Determine PK, target engagement, and efficacy of h-cGASi’s in
human iPSC-derived microglia and organoid model. The two best leads showing high brain exposure will be
assessed in PK studies in wild-type mice and evaluated in human iPSC-derived microglia and organoids. Lead
h-cGASi’s must reduce key biomarkers, such as Cxcl4, Ifnb, and TBK1/pTBK1. We expect to identify at least
one lead h-cGASi that reduces key biomarkers in cells and organoids, is brain permeable, shows no toxicity in
mice, and does not have off-target effects. This will lead to development of novel cGASi’s that are likely to
reprogram toxic microglial responses and protect against tau-related cognitive decline.

Public health relevance
Narrative Aeton Therapeutics is developing cGAS inhibitors as novel therapies for the treatment of Alzheimer’s disease (AD), with the goal of blocking a pathway that results in production of interferon-β and neurotoxic chronic neuroinflammation. AD is the most common form of late-onset dementia, which affects an estimated 5.7 million Americans and has an annual estimated cost of $305 billion. Development of an effective cGAS inhibitor with potent activity in humans has the potential to improve the treatment, survival, and quality of life of the millions of Americans suffering from AD.